Endoplasmic Reticulum Stress Responses in Pain

Summary
Peripheral nerve injury activates pattern recognition receptors (i.e. Toll-like receptors) in immune cells, thus
triggering and maintaining inflammation, and ultimately determining the perpetuation of pain. Immune cell
activation demands high levels of protein synthesis, folding and secretion, which are regulated by the
endoplasmic reticulum (ER). An excessive demand in protein handling can evoke ER stress (accumulation of
misfolded proteins) and consequently trigger robust activation of the unfolded protein response (UPR). IRE1α-
XBP1 is the most evolutionarily conserved arm of the UPR and can be directly activated via Toll-like receptor
engagement to promote the expression of pro-inflammatory factors. We have unveiled that conditional knockout
(cKO) mice devoid of IRE1α/XBP1 in immune cells (Ern1/Xbp1f/f-Vav1cre), display decreased PGE2 production
in vivo, reduced nociceptor responsiveness, and faster resolution of non-reflexive pain-related behaviors
following paw incision. Similarly, these cKO mice exhibit improved recovery after partial sciatic nerve ligation
(PSNL). Through unbiased genome-wide transcriptomic analyses we found that IRE1α-XBP1 signaling in
leukocytes is critically required for the induction of prostanoids, cytokines and other novel factors such as Nupr1
(associated with chronic inflammatory diseases in humans). Of note, IRE1α-XBP1 overactivation has been
correlated with painful or inflammatory conditions in humans. Therefore, we hypothesize that IRE1α-XBP1
signaling in leukocytes governs peripheral neuro-immune interactions and the development of chronic
pain. Using cutting-edge experimental approaches, we will accomplish the following specific aims: 1) Determine
how IRE1α-XBP1 signaling dictates the dynamics of immune cell infiltration and molecular changes that drive
behavioral non-reflexive hypersensitivity following peripheral nerve injury. We postulate that the IRE1α-XBP1
arm operates as a key modulator of pro-algesic factors in immune cells, and that Nupr1 is a novel XBP1-
dependent factor (using ChIP PCR) implicated in PSNL. 2) Establish how IRE1α-XBP1 activation governs
individualized immune cellular reprogramming and how this drives the cross-talk with nociceptor afferents
following peripheral nerve injury. Our hypothesis is that the reduced hypersensitivity observed in our cKO mice
following PSNL is determined by discrete gene signatures in specific injury-infiltrating leukocyte subsets (using
single cell RNA sequencing), and by the acquisition of a less responsive phenotype in nociceptors (via in vivo
intracellular DRG recordings). 3) Define the therapeutic potential of inhibiting IRE1a to accelerate recovery from
PSNL. We posit that pharmacological inhibition of IRE1α using MKC8866 (RNAase domain inhibitor) or KIRA6
(kinase domain inhibitor) will prevent or treat chronic neuropathic pain. Our team has expertise in pain biology
and neuroimmune interactions (Romero-Sandoval), immunology and ER stress biology (Cubillos-Ruiz), in vivo
electrophysiology (Boada), and scRNAseq and bioinformatics (Miller). Thus, we are uniquely positioned to test
our innovative hypothesis and contribute to the development of novel non-narcotic treatments for chronic pain.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injury induces pain that lasts more than three months (chronic neuropathic pain) in patients, which affects their quality of life and has a substantial economic and social impact due to limited treatment options. Thus, the medical community needs novel and more effective therapies to prevent the development of chronic neuropathic pain. The proposed studies will provide the foundation for a new non-narcotic therapeutic strategy that has the potential to reduce the incidence of chronic pain following nerve injury.